An integrated exercise and bladder training intervention to reduce falls in older women with urinary incontinence

Project Summary/Abstract
Urgency urinary incontinence (UUI) is a biomarker of falls risk and disproportionately affects older minority
women living in urban communities. Over 50% of an estimated 10 million women age 70 and older with UUI will
experience a fall. A fall compounds the functional dependency already present in older women with UUI making
their quality of life worse than that following a stroke. This proposal addresses a key research gap: existing fall
prevention interventions cannot be applied to women with UUI and effective interventions that reduce falls in
older community-dwelling women with UUI are lacking. Our objective is to establish the effectiveness of a novel
multidimensional intervention to reduce falls in older women with UUI. This intervention is based on the
hypothesis that falls in older adult women with urinary incontinence are the result of urinary urgency related
anxiety in the setting of reduced lower limb muscle strength, poor balance, and environmental hazards. Our trial
will show that a tailored intervention that addresses each of these interdependent factors through integrated
behavioral bladder training and urge suppression, strength and balance exercises, and home hazard
assessment will reduce falls and improve urinary incontinence in older community-dwelling women with UUI.
The investigators of this proposal have already developed and validated the intervention in pilot studies and now
propose a randomized controlled trial of 314 women to rigorously establish its effectiveness. Our specific aims
are: 1) To determine the effect of a tailored integrated exercise and bladder training intervention on falls in older
women and 2) To determine the effect of a tailored integrated exercise and bladder training intervention on
urgency urinary incontinence in older women. The trial will use a community-engagement approach to recruit
women living in an urban core community with high proportion of minorities. This trial will be the first adequately
powered study to test an intervention for reducing falls in older community-dwelling women with urgency urinary
incontinence and also the first adequately powered study to test the efficacy of a physical exercise intervention
for the treatment of urinary incontinence. This study will have significant public health impact because it will
establish the clinical effectiveness of a scalable intervention that targets two common highly morbid conditions:
falls and incontinence in older women.

Public health relevance
Project Narrative The proposed research is relevant to public health because it seeks to establish the efficacy of an innovative and scalable intervention to addresses two prevalent and debilitating conditions, falls and urinary incontinence, which together affect 1 in 2 older adult women. Successful completion of this project has the potential to significantly decrease the substantial morbidity that results from these two conditions in community-dwelling women and thus is relevant to the NIH’s mission to enhance health and reduce disability.